Plasmodium falciparum gametocytogenesis in vitro and in vivo

Malaria transmission in the field requires the production of sexual stage Plasmodium parasites, called
gametocytes, that once taken up by an Anopheles mosquito fertilize and differentiate into infectious
sporozoites. Sporozoites collect in the mosquito salivary gland and can be introduced to a new host during a
blood meal. As would be expected, higher gametocyte levels in the human host's peripheral blood increase the
chance of productive transmission to a mosquito, but gametocyte levels vary between individuals and the
factors that determine carriage are unknown. No tools are available to identify individuals that carry immature
P. falciparum gametocytes to determine the efficiency of stage V gametocyte development or to target carriers
for treatment before they become infectious. In a recent field study of 260 symptomatic malaria patients in
Ghana we developed a new assay to quantify circulating gc-rings and found a wide range of gametocyte
conversion rates. In 20% of the samples the ratio of gc-rings to asexual rings was > 4.9% with a high of 70%,
while 24% of the samples had no gc-rings, which clearly demonstrates variation in gametocytogenesis
between patients. Using this data we found that gametocyte conversion was positively associated with
parasitemia, while body temperature was negatively associated. We also found high gametocyte conversion
was associated with a specific allele of a gene previously reported to be critical for gametocyte production in
vitro, gametocyte development 1 protein (gdv1) and the upregulation of three enzymes. We hypothesize that
these factors and genes are causally associated with P. falciparum gametocytogenesis and plan to test this
directly in vitro (Aims 1 and 2). We will also extend our in vivo analysis of gametocyte dynamics to one of the
major infectious reservoirs in West Africa, asymptomatic children 5-15 years old (Aim 3). Children will be
followed longitudinally from the start to the end of the malaria season in Ghana (May-Nov) and again in the dry
season (Apr) over the course of 2 years in 2 different sites. This prospective longitudinal study design will allow
for the first time the evaluation of asexual and gc-ring production as well as gametocyte maturation/survival
and host parameters in the same individual over time. The two week sampling period is the same as the time
needed for a P. falciparum gc-merozoite invaded RBC to mature to a stage V gametocyte. The direct
comparison of gc-rings and stage V gametocytes produced two weeks later will indicate whether gc-ring levels
can be used to predict the number of stage V gametocytes found in the circulation two weeks later or whether
some individuals effectively clear sequestered gametocytes prior to maturation. Evidence for gametocyte
clearance would provide new targets for transmission-blocking interventions. Together, the data from all three
aims will allow us to determine whether the host environment or the parasite or host genotype are major
drivers of malaria transmission, providing critical information for the design of malaria control strategies.

Public health relevance
Project Narrative New strategies are required to block the spread of malaria, which still is responsible for over 200 million clinical cases and the deaths of 0.43 million people each year. The goal of the project is to advance the understanding of the production of the transmission stage, the gametocyte.